Watson Phase I COBRE Renovation

ALTERATION / RENOVATION PROJECT SUMMARY / ABSTRACT
The Center of Biomedical Research Excellence in Multiscale Biomolecular Sensing (MBS) will unite experts in
biology, biochemistry, chemistry, spectroscopy, materials science, and biomedical engineering to develop novel
mechanisms and tools for sensing of biochemical and biological processes that will directly impact a wide range
of human diseases. A major goal of this COBRE proposal is to recruit and hire outstanding faculty members that
will strengthen University of Delaware’s footprint in Biomolecular Sensing and increase the University's activity
in biomedical research, and a particular need within the proposed Center is expertise within the area of
Bioinorganic Chemistry. Suitable space to house a faculty member working in this area exists within the
Department of Chemistry and Biochemistry, however, the fume hoods within that laboratory have exceeded their
usable lifetime and are no longer safe for use in chemical research.
To create a suitable and safe research space for the proposed hire, we will renovate these laboratories by
replacing the fume hoods with new fume hoods outfitted for modern synthetic chemistry research. We will also
complete cosmetic upgrades to the laboratories and adjacent offices to make the space suitable for a new faculty
member and research students.
Success of the proposed research plan will result in attractive and safe research and office space for a new
bioinorganic faculty member, and it will position the MBS Center to successfully complete the faculty recruiting
goals for the Phase 1 COBRE.

Public health relevance
PROJECT NARRATIVE Project Narrative is not required in this component